Tecan Resolvex for University of Utah

Project Summary / Abstract
This proposal requests funding for a Tecan Resolvex A200 (Resolvex) to the Metabolomics Core (Core) for
two primary purposes, to: 1) increase sample processing throughput, and 2) decrease human sample
processing error.
The Core provides a wide array of mass spectrometry-based services including metabolomics, lipidomics, flux
tracer analysis, and targeted metabolite/drug quantitation. Over the past four fiscal years, the Core has served
an average of 53 Principle Investigators (PI) per year, 40 PI’s from 20 departments at the University of Utah
(UU) and an average of 13 users from outside academic institutions. The Core only tracks funding sources
from UU researchers with an average of 23 NIH grants served per year. Other major funding sources include
the American Diabetes Association, DOD, HHMI, JDRF, NSF, USDA as well as other foundation grants. The
Core currently process approximately 10,000 samples a year, with most extractions performed manually using
liquid/liquid extraction methods. This work is tedious, low throughput and prone to human error.
Solid phase extraction (SPE) methodology has long standing in both academia and industry for the extraction
of drugs and pesticides from biological matrixes. Recently, several technologies that use SPE for
metabolomics and lipidomics have been introduced by Agilent. These technologies serve two functions, 1) they
remove interfering chemical entities from a sample matrix, and 2) due to their 96-well format, increase sample
through put. In order to meet the ever-increasing demand for Core services, a high throughput modernization
plan is necessary. The Resolvex is central to this, it is needed to perform automated sample wash and elution
steps from 96-well SPE plates by the precise addition of solvents to each well. The positive pressure
mechanism used to elute solvents from each well ensures uniform sample preparation. Without this device, it is
very difficult to leverage all the advantages provided by these new SPE technologies.
The Resolvex is central to the modernization plan of the Core and will immediately make an impact in both
sample throughput and data quality. It will be immediately used for the extraction and purification of both
metabolites and lipids. In addition, by limiting the human error associated by manual pipetting, it will make a
considerable difference in data quality.

Public health relevance
Project Narrative This solid phase extraction machine will aid investigators at the University of Utah by decreasing both the time needed for extracting metabolites and lipids from biological samples and the human error associated with sample preparation. This will increase both sample throughput and confidence in the end results obtained after sample analysis by mass spectrometry.